CLINICAL RESEARCH CENTER VOLUNTEER DATABASE

There are no specific hypotheses for this protocol. It is set up specifically to be a service to investigators who study volunteers on an intermittent basis. Data about subjects is obtained from questionnaires, after IRB-approved consent forms have been signed, and released only to investigators who have been approved through the usual GCRC procedures. The investigator is responsible for contacting and informing the volunteer about the proposed study. Information about the volunteer is limited to demographics, social history, health history, and participation in previous studies.